Administrative Core

Project Summary
The Mount Sinai Center on Health and Environment Across the LifeSpan (HEALS) Administrative Core
provides scientific direction, fiscal management, organizational initiatives, and career development programs.
Our goal is to bring Environmental Health to more and more research programs locally and nationally because
environment is critical to all chronic diseases. Since our Center’s founding in 2014, we have built a strong
NIEHS funding base with 28 active NIEHS grants- going from the 27th ranked institution in NIEHS funding 10
years ago to #2 today. We also have 47 other grants from other NIH Institutes and extramural programs
working in environmental health science (EHS). The Center’s Career Development Program supports a Center
Scientist with funding and access to career enhancement programs. This program has been particularly
successful as four of the six past Center Scientists have received their first R01 and a fifth recently received a
9th-percentile score on her application. To advance EHS under our life course theme, the Administrative Core
supports Research Groups in exposomics, mixtures, and clinical environmental research, bridging silos and
bringing EHS to all of Mount Sinai through seminars, workshops, and journal clubs to discuss cross-cutting
EHS issues. The Administrative Core also oversees 4 Cores: an Integrated Health Sciences Facility Core that
supports biomarker research and population health research, a Biostatistics and Data Science Facility Core
that supports environmental health/toxicology data analysis and generates analytic methods for exposomic
data, and a clinically-oriented Phenotyping and Environmental Modifier Facility Core that supports state-of-theart
health measures. Our Community Engagement Core implements multi-directional communication and
partnership locally, and its Stakeholder Advisory Board supports the Administrative Core by providing counsel
on policy and environmental issues of local importance. Our Pilot Projects Program has been remarkably
successful, with 48 of 78 funded pilot grants awarded to ESIs and a greater than 40:1 return on investment.
The Administrative Core receives scientific guidance from an External Advisory Board of EHS experts and
administrative and institutional guidance from an Internal Advisory Board, composed of senior Mount Sinai
Faculty who are directors of other NIH-funded P30 Centers. Our Center leverages the Mount Sinai Institute for
Exposomics Research (see Dean’s letter) to bring additional support to accelerate the Center’s scientific
breakthroughs in EHS. Our continued expansion is ensured by the robust infrastructure and leadership within
the Administrative Core allowing us to leverage institutional resources and propel the Center forward. In this
renewal cycle, we will focus on bringing EHS to additional Mount Sinai research programs through
partnerships with our CTSA, other Mount Sinai based P30 Centers and with a new partnership with City
University of New York(CUNY), the largest public university in New York State.